Prospective Practice-Oriented Research Project: Predicting hospitalization and disengagement with automated speech and language analysis

Abstract
The goal of this prospective practice-oriented project is to develop a means for predicting rehospitalization and
disengagement in coordinated specialty care (CSC) for psychosis. CSC has demonstrated efficacy in
improving outcomes, yet challenges persist with rehospitalization and treatment disengagement. There is an
urgent need for predictive tools that are scalable and efficient. Automated speech and language analysis holds
several advantages: they are accurate markers of mental states related to psychosis, assessments can be
conducted repeatedly and longitudinally, and little specialized equipment or training is required to collect
necessary speech samples. The study will be conducted within the ESPRITO hub of the EPINET consortium,
drawing upon the expertise of a multidisciplinary team in psychosis, early intervention, and natural language
processing. Feature extraction will be approached through data-driven (Aim 1A/2A) and insight-driven (Aim
1B/2B) methods based on existing datasets. The existing data for Aim 1 will include 200 clinical notes
describing individual participants’ early warning signs for psychosis relapse, and relevant data for Aim 2 will
include 400 psychotherapy progress notes from the health records. Themes related to the outcomes of interest
will be automatically identified using topic modeling. Features will be derived by calculating the semantic
distance between the identified themes and the content of prospectively collected transcripts. In the insight-
driven approach, the study team will review and interpret existing data in the context of prior work and clinical
expertise; hypothesis-driven acoustic and NLP features will be identified and calculated. Prospectively
collected speech data from psychotherapy sessions (n=150 participants; ~1200-1500 sessions) will then be
used to develop and test predictive algorithms for hospitalization (Aim 1C) and disengagement (Aim 2C). The
outcomes will be considered in a time-to-event setting as well as in a binary variable setting (hospitalization in
30 days & 90 days, disengagement in 90 days & 6 months). The primary analytic strategy for time-to-event
outcomes will be based on regularized Cox regression, which allows for the selection of features significantly
associated with hazard function for hospitalization or disengagement. Additionally, with a focus on improving
prediction accuracy, machine learning-based survival and classification models will be considered (e.g. Deep
Convolutional and Deep Recurrent Neural Network models: CNN-Surv & RNN-Surv). Speech and language
features recorded from all sessions across all participants will be used. Training and testing for all models will
be based on the standard 60%/20%/20% random split into training, validation, and test datasets. Key
deliverables include the development of speech-based tools capable of identifying individuals at risk for
rehospitalization and treatment disengagement in real-time, which enables timely interventions to mitigate
adverse outcomes. Successful completion of this project could pave the way for future randomized clinical
trials to evaluate the effectiveness of real-time implementation in improving outcomes within CSC.